2022 Annual Conference Grant: American Society of Preventive Oncology

ABSTRACT. The mission of the American Society of Preventive Oncology (ASPO) is the exchange and translation of
scientific information to reduce the cancer burden and for the continued development of investigators involved in
cancer prevention and control. The 46TH ASPO Annual Meeting will be held at the Marriott Tucson University Park,
Tucson, Arizona, March 13-15, 2022.
The specific aims of the annual meeting and this conference grant are to: 1) provide multidisciplinary forums for the
exchange of scientific information; 2) foster implementation and broaden dissemination of scientific discoveries; and 3)
provide exceptional professional development to investigators at any career stage, but especially early career
investigators, to maximize their potential for success.
This application requests partial support for the 2022 Annual Meeting, which is a keystone of this multidisciplinary
organization and the preventive oncology community. ASPO’s annual meeting provides a high-quality program that
fosters new opportunities for early career, mid-career, and senior investigators whose careers are focused on the
primary, secondary, and tertiary prevention of cancer.
The 2022 Meeting consists of 4 symposia, 1 panel discussion, 2 concurrent workshop sessions, 4 submitted paper
sessions, 2 award lectures, 4 Special Interest Group sessions, a networking mixer, a poster session, and—for the third
year—a Community Science program. Pre-meeting workshops include multiple professional development sessions, a
meeting of cancer center Associate Directors and Program Leaders for Cancer Prevention and Control, and a meeting for
NCI training grant directors. Roundtable discussions are organized by Special Interest Groups tasked to move the field
forward in specific topical areas highly relevant to the ASPO mission.
Meeting planners take satisfaction surveys from previous annual meetings into account. Abstracts will be solicited
beginning in September 2021. The 16 abstracts receiving the highest peer reviewed rankings will be published in Cancer
Epidemiology, Biomarkers & Prevention, and presented during paper sessions and the poster session. Over 175 posters
are anticipated be presented.
Multiple initiatives including this conference grant—which requests travel support for minority investigators, early
career scientists, and community scientists—enhance the diversity of the meeting attendees, program committee, and
invited speakers. All meetings are held in non-smoking, ADA accessible conference facilities. Journal and online
advertisements, email, and direct mail will publicize the meeting. Over 400 participants are expected to attend. Speakers
and participants are from multiple disciplines in cancer prevention and control research and represent fields concerned
with translating evidence into effective prevention and control programs. By fostering communication among
multidisciplinary professionals, ASPO meetings have been extraordinarily successful at reaching the society’s goals of
supporting mentoring, encouraging dialogue, and promoting innovative progress in cancer prevention and control.

Public health relevance
PUBLIC HEALTH RELEVANCE The American Society of Preventive Oncology (ASPO) is a distinctive society that emphasizes multidisciplinary approaches to cancer prevention and control research; ASPO fulfills a unique niche enhancing the health of the public and supporting the continued development of investigators involved in cancer prevention and control. This application requests partial support—including travel funds for minority and early career investigators and community scientists— for ASPO’s 46th Annual Meeting, to be held at the Marriott Tucson University Park, Tucson, Arizona, March 13-15, 2022. The events and activities available at ASPO’s 2022 Annual Meeting will influence scientific collaboration and cancer communications beyond the conference.